Summer Research Experience for Medical Students in Inflammation and Infectious Diseases

PROJECT SUMMARY
Continued funding is requested to support the NIAID-T35 training program at Loyola University Chicago Stritch
School of Medicine. Our program introduces early-stage medical students to the challenges and excitement of
research by providing a mentored summer research experience with the ultimate goal of inspiring trainees
toward academic careers that incorporate basic biomedical and clinical research. The T35 Research Training
in Immunology and Infectious Diseases (REIID) program exists as a dedicated, NIAID-focused research and
career development program that leverages the successful administrative framework of our Student Training In
Approaches to Research (STAR) Program. The T35-REIID program provides students between their first and
second year of medical school with a focused eight-week mentored training experience pursuing NIAID-related
research resulting in completion of a research project and formal presentation of their work. The Stritch School
of Medicine is a rich academic environment and a leading institution in immunology and infectious disease-
related research and clinical care. We have a team of thirty-one experienced mentors whose research covers
epidemiology; genetics; molecular, cellular and pathophysiological mechanisms of disease; translational
research; and patient-oriented clinical research. The student’s full-time research training is supplemented with
didactic conferences on topics including experimental design, data management, responsible conduct of
research, professional development, and presentation skills. Trainees are chosen through a competitive
process based on their proposed research plan and goals for the summer experience. The T35-REIID program
includes student assessments to evaluate the quality of the research experience and didactic offerings as well
as our success at encouraging students to pursue academic careers that include research.

Public health relevance
PROJECT NARRATIVE The proposed training program provides mentored summer research opportunities for early-stage medical students with the goal of inspiring a passion for biomedical investigations. Through hands-on research training supplemented with didactic conferences on research and career development topics, we will introduce students to the excitement and challenges of research and encourage them to pursue careers that integrate research with clinical care.